Developing tools to study HPV16 in oropharyngeal tissues

Abstract
Human papillomaviruses (HPVs) contribute to 5% of global cancer cases, with HPV-associated oropharyngeal
cancers now surpassing cervical cancers in the United States, representing an epidemic. Notably, HPV16 is the
leading cause of oropharyngeal cancers. Following infection, HPV maintains its genome in basal epithelial cells,
exploiting cellular processes for replication via oncogene expression, while the balance between transformation
and productive infection remains a crucial inquiry. To study the HPV16 lifecycle and address the role of HPV16
in oropharyngeal cancer, we generate primary tonsil-derived epithelial cells that maintain the HPV16 genome.
For unclear reasons, it is technically challenging to generate these cell lines, creating a bottleneck for
reproducible research in this area. To address this, we will develop molecular tools using primary epithelial cells
from tonsillectomies, a physiologically relevant model for HPV16-driven oropharyngeal cancer. Aim 1 will develop
a complementation assay to enhance the recovery of cells with episomal viral DNA.
Furthermore, different HPV16 variants may exhibit varying oncogenic properties and replicative capacities in cell
culture. In Aim 2, we will quantify lifecycle stages and tumorigenicity across HPV16 variant genomes using
primary tonsillar epithelial cells. Despite technical hurdles, studying HPV16 in the lab is vital for understanding
the viral role in the development of oropharyngeal cancer. Developing novel methods to select infected cells and
discern variant-specific phenotypes promises to advance HPV research, aligning with the NIH mission and fitting
the scope of an R03 proposal. Future research will use these tools to ask biological questions, compare and
contrast viral types (e.g., HPV16 vs HPV18), study HPV16 variants further, and aid in understanding the role of
HPV16 in oropharyngeal cancers.

Public health relevance
Project Narra+ve HPVs, notably HPV16, contribute to 5% of global cancer cases, with HPV-associated oropharyngeal cancers surpassing cervical cancers in the US. We aim to develop molecular tools to study HPV16-driven oropharyngeal cancer, addressing challenges in generaDng primary cells with episomal viral DNA, and quanDfying lifecycle stages and tumorigenicity across HPV16 variants, vital for advancing research and understanding HPV's role in oropharyngeal cancers.